EFFECT OF CISAPRIDE IN PATIENTS WITH GASTROINTESTINAL REFLUX DISEASE

Evaluate the effect of cisapride and esophageal stimulation on salivary secretion on epidermal growth factor, transforming growth factor alpha, nerve growth factor, fibroblast growth factor and interleukin 6 in healthy subjects and those with gastroesophageal reflux.